International Conference on Advances in Quantitative Laryngology,Voice and Speech Research (AQL)

Project Abstract
This proposal requests support to convene the next three International Conferences on Advances in
Quantitative Laryngology, Voice and Speech Research (AQL). During the 5 years of requested support, the
14th, 15th, and 16th AQL (2021, 2023, and 2025 respectively) will be assembled. The 14th AQL will be held in
Bogota, Colombia, South America, June 9 and 10, 2021 (pre-conference workshops June 7 and 8), the 15th will
be in Phoenix, AZ, USA, in April 2023, while location of the 16th AQL conference will be determined during the
2021 conference (potential locations in South Korea or Germany). AQL is a valuable scientific meeting in the
field of voice research and is regarded by voice and speech science specialists as a high quality international
scientific meeting. AQL fosters the exchange of theoretical, experimental, and methodological advances,
thereby progressing the translational and clinical aspects of voice and speech science. This multidisciplinary
conference brings together scientists, clinicians, and students from around the world in various disciplines
including Engineering, Biology, Physics, Otolaryngology and Speech Pathology. This proposal will allow for
conference development and continuity to ensure an equitable conference that maintains its cutting-edge focus
and provide support for students and early career investigators. The continuity of support will also ensure
metrics and evaluations from previous conferences to be used to guide future AQL planning. The goals of this
proposal are: to promote and support the education and development of young and underrepresented
investigators in the voice and speech research community, organize special sessions on emerging research
areas specific to quantitative laryngology, voice and speech research, to develop and foster digital networking
strategies to provide a more inclusive and equitable conference, and to establish a Steering Committee. NIH
funds are requested to provide support for child/family care, conference support for students and keynote
speakers, students to assist Chair/Co-Chairs with various logistic needs, before, during and after the AQL
conferences, website design and management, and streaming support during the meeting. In the off-
conference years, necessary activities will include: student research trainee support, maintaining AQL website,
Steering Committee meetings for conference evaluation and planning.

Public health relevance
Project Narrative This proposal seeks funding for the upcoming 14th, 15th, and 16th International Conference on Advances in Quantitative Laryngology, Voice and Speech Research (AQL) and the associated workshops and pre- conference, taking place in 2021, 2023, and 2025. AQL is an important international scientific meeting specialized in translational research and methods for measurement and modeling of voice and speech. Special emphasis will be given to promoting young investigators and underrepresented populations, digital networks to support a more inclusive and equitable conference, and to develop a permanent AQL website to help disseminate AQL information.